MIELHSS - Admin Core

Administrative Core Project Summary
The Massachusetts Institute for Equity-focused Learning Health System Science (MIELHSS) will be a
driving force in promoting scientific progress in Equity-focused Learning Health System Science (E-LHS),
developing a robust and diverse pipeline of E-LHS scientists, and creating the culture change and broad alliance
that is needed to accelerate progress in Massachusetts and beyond. Our framework for training and research
will advance the quintuple aim of healthcare: better health, improved patient experiences, care team wellbeing,
and health equity, at lower cost.
All Cores, scholar, and community activities will be organized and managed by the Administrative Core. Within
this Core, the team of Director and Associate Directors brings a strong, informed, and progressive vision of
PCOR/CER and embedded E-LHS research. Together they develop, oversee, and integrate MIELHSS activities,
with input from an engaged Internal Executive Committee and external experts who serve on the MIELHSS
External Advisory Committee. In addition to training the future workforce, creating data synergies around equity
and social drivers of health, and creating an integrated culture of E-LHS, we will leverage the collective capacity
of Institute partnerships to advance research methods in embedded LHS, PCOR/CER, and E-LHS.
The Administrative Core will also coordinate MIELHSS activities with the administrative and scientific leadership
at Harvard Affiliates, UMass, Beth Israel Lahey Health System, Federally Qualified Health Centers, Safety Net
Clinics, the Boston VA, and the Massachusetts League of Community Clinics. We will create and enhance
mechanisms to facilitate communication and meaningful engagement across Massachusetts, and go beyond
traditional dissemination by proactively offering an E-LHS consultation service to help create roadmaps for other
MIELHSS organizations interested in adopting successful interventions. The broad and deep expertise of the
MIELHSS team, combined with rigorous and regular self-assessments of the program, will enable the MIELHSS
to evolve activities nimbly, to embrace healthcare and societal change, and to drive advances in developing
future leaders and impactful science in and for learning health systems.

Public health relevance
Administrative Core Narrative The Administrative Core of the Massachusetts Institute for Equity-focused Learning Health System Science (MIELHSS) coordinates and manages all Institute activities across its Research Education and Research Data Cores. The role of the Administrative Core is to: 1) Provide leadership, direction, and oversight of MIELHSS; 2) Foster internal and external communications and engagement across health systems, community and stakeholder partners, scholars, mentors, projects, and cores to create a broad and sustained culture of integrated E-LHS science; and 3) Advance E-LHS research methods through a methods incubator. We will measure success using metrics such as grant submissions and publications while also by measuring health system engagement in MIELHSS activities and sustained implementation and widespread adoption of equity-focused interventions and health system improvements.